USING CLASSICAL CONDITIONING TO STUDY THE CEREBELLUM

The cerebellum is a critical component of the motor system as revealed by the severe motor dysfunction seen with cerebellar pathology. The objective of our work is to determine the mechanisms by which the synaptic organization of the cerebellum contributes to motor function. To accomplish this we will use a relatively simple form of motor learning; classical conditioning of eyelid responses in rabbit. Eyelid conditioning offers numerous advantages as an experimental preparation. In particular, the way in which the stimuli used in conditioning activate cerebellar afferents provides a powerful yet simple means to study the input/out properties of the cerebellum. These advantages will be used to address three fundamentally important issues: 1) what are the loci of synaptic plasticity in the cerebellum that contribute to motor learning; 2) what factors control the induction of this plasticity; 3) how does this plasticity, in combination with the synaptic organization of the cerebellum, contribute to the learning and to the expression of movements. Five specific aims are proposed. 1) Determine cerebellar involvement of the timing of conditioned movements. These studies extend preliminary data indicating that response timing is severely disrupted by cerebellar cortex lesions. This suggests that conditioning is mediated by synaptic plasticity at two cerebellar sites, and how these sites contribute in parallel to the expression of movements. 2) Characteristics cerebellar neuron activity during the execution of differently timed conditioned movements. These studies will use single unit recordings to study the cerebellar cortex processing contributing to response timing. 3) Determine the role of the cerebellar cortex in extinction of conditioned movements. These studies are based on preliminary data suggesting the cerebellar cortex is required for extinction of conditioned responses. These experiments address the fundamental issue of whether the cerebellar cortex is involved with or necessary for the learning of movements. 4) Identify the loci of synaptic plasticity responsible for motor learning. These studies combine stimulation and unit recordings to distinguish between cerebellar and post-cerebellar sites of synaptic plasticity in motor learning. These studies will help resolve ongoing debates concerning the role of cerebellar synaptic plasticity in motor learning. 5) Characterize expectancy-related modulation of climbing fibers. These studies use various type of conditioning trials to study spontaneous and stimulus-evoked climbing fiber responses when stimuli are expected and when they are expected. This is central to the putative role of climbing fibers as an error signal which induces cerebellar plasticity essential for motor learning. Completion of these aims will help identify cerebellar sites of synaptic plasticity, how this plasticity is involved in both the learning and the execution of movements, and how together these mechanisms permit movements to be adaptively modified by experience to improve motor performance.